Annual OHDSI Symposium

Project Summary
The Observational Health Data Sciences and Informatics (or OHDSI, pronounced "Odyssey") program is a multi-
stakeholder, interdisciplinary collaborative formed to bring out the value of health data through large-scale
analytics. All our solutions are open-source. OHDSI has established an international network of researchers and
observational health databases with a central coordinating center housed at Columbia University’s Department
of Biomedical Informatics. As a collaborative, one of our greatest strengths comes from working together with
other stakeholders across the broader healthcare community. By connecting with those on the frontlines of
medical decision making, we can ensure our goals are aligned with the needs of patients, clinicians and
regulatory agencies. To engage with this broader audience, we propose holding an annual symposium with the
objective of showcasing OHDSI’s achievements and offering hands-on training for OHDSI tools and methods.
Furthermore, the symposium will provide a forum to discuss challenges facing large-scale observational research
with a broad range of stakeholders, and request external feedback on how OHDSI collaboration could further
foster an ecosystem designed to satisfy the needs of the healthcare community. This symposium will be a
continuation of our previous symposia which has been offered annually since 2015 and hosted a wide range of
stakeholder groups such as patients, clinicians, researchers, industry and government. At the event, OHDSI
collaborators will present OHDSI’s vision and demonstrate our commitment to open science by sharing results
from our most recent collaborative studies, carried out across our international research community.
Presentations will be interactive and provide participants tangible examples of how observational data has been
used to generate real world evidence about disease natural history and the effects of medical interventions. The
annual symposium will give participants an opportunity to provide input on the priorities and future direction for
how the OHDSI community should advance the research, development, and applications of observational
research. This input will ensure the evidence generated within the OHDSI community is designed to answer the
questions most important to patients, payers, providers and policy makers.

Public health relevance
Project Narrative: As a vibrant research community, OHDSI aims to develop the methods and open-source analytics for large- scale research and lay the foundation for scientific best practices in observational health research. The annual symposium offers a forum for OHDSI collaborators to share our vision and align our goals with the needs of the broader healthcare community, ultimately enhancing healthcare decision-making and improving outcomes for patients.